Administrative Core

ABSTRACT/SUMMARY: ADMINISTRATIVE CORE
The proposed P50 Center, titled Partnering for Equity: An Academic and Community Alliance to Eliminate
Disparities throughout the Fibroid Experience (PEACE), is a national community academic partnership created
to improve health equity throughout the uterine fibroid experience. This innovative and visionary center will be
supported by an Administrative Core that will provide overall support for the management and coordination of
PEACE Center activities across its three Projects and its Community Partnership, Education and Outreach Core
and the Center’s Community Stakeholder and Advisory Board (CAB). The Administrative Core staff will record,
distribute and archive minutes from all Center meetings. The Administrative Core will also organize and promote
an Annual PEACE Symposium to celebrate fibroid-related science, patient advocacy, and progress. The
following objectives of the Administrative Core are central to meeting the Center’s goals: 1) provide a focal point
for administration and coordination between sites (University of Michigan, Harvard TH Chan School of Public
Health, Henry Ford Health, Boston University, University of California, Irvine), projects, committees, and boards
to foster efficiency and consistency; 2) ensure completion of all compliance activities, including institutional
review board (IRB) activities, training, reports to the sponsor, and budgetary reports; 3) administer the Pilot Grant
Program; and 4) administer, support, and track dissemination activities including town halls, open houses,
presentations, abstracts, and manuscript submissions. The Administrative Core will be responsible for
coordinating the activities of the multiple institutions involved in this collaborative and ensuring that component
plans are implemented to fulfill the Center’s goals in a timely fashion. It will support the organizational and
governance structure of the PEACE Center and will manage and support the entire range of proposed Center
activities, including ensuring that community partners and organizations are compensated in a timely fashion.
The Administrative Core will be responsible for administering the Pilot Grant Program including ensuring a
national applicant pool and organizing an objective process for selection of awardees in partnership with the
CAB members. The Administrative Core will financially manage the Pilot Grant awards and will facilitate
multidisciplinary collaboration, support, and mentoring of Early-Stage Investigators. The Administrative Core will
ensure the dissemination of PEACE Center work and findings to a broad constituency—from community
organizations to scientists, clinicians, and patients. It will track document development, manuscript submissions,
development of a public website, and organization of community-based dissemination events. To promote the
work of the Center, the Administrative Core will also organize an Annual PEACE Symposium that will feature
presentations from Pilot Grant awardees. In summary, the Administrative Core represents an integral component
needed for the success of this multidisciplinary, multi-institutional, and innovative research program.